Gene expression profiles in lung cancer using cDNA array

Serial analysis of gene expression (SAGE) is a highly quantitative method that determines the relative expression of each transcript present in any particular tissue of interest. We have recently performed a comprehensive analysis of gene expression using hierarchical clustering and our SAGE result from lung cancers. We found that the neoplastic state as well as the cancer subtypes could be distinguished based on gene expression patterns identified by SAGE. Furthermore, we identified 115 highly differentially expressed transcripts that could also provide the same distinction. Many of these genes were either previously identified as lung tumor markers or revealed molecular characteristics unique to the tumor tissue analyzed. cDNA array is a complementing method that allows for rapid analysis of many genes that are present at a higher level in the tissues. Using Affymetrix cDNA arrays, we have surveyed 50 primary lung tumors to determine the gene expression pattern among these tumors. Analysis are currently underway to determine the association of gene expression patterns obtained by cDNA array with the clinical and genetic phenotypes of lung cancer.